An advanced functional MRI study of frontostriatal injury in adults with HIV

PROJECT SUMMARY/ABSTRACT In the era of combination antiretroviral therapy (cART), the prevalence of HIV-associated neurocognitive disorders, or HAND, remains high in people with HIV (PWH); as a result, there is increasing pressure to identify neural targets for effective therapies. However, to develop effective HAND treatments, there is a strong need for the development of sensitive behavioral tests that can quickly screen and effectively identify probable neurocognitive impairment in PWH and biomarkers that can accurately determine HAND status and evaluate therapeutic effects. This 5-year cross-sectional and longitudinal study is theoretically driven and specifically designed to tackle these challenges. Neural injury to the frontostriatal circuits (plus hippocampus, thalamus, and other associated regions) has long been recognized as a key component in HAND; however, the association between frontostriatal injury and HAND status remains to be elucidated. Recent findings suggest that injury to different key regions in the frontostriatal circuits may play differential roles in HAND status: frontal injury is more prevalent in PWH, but striatal injury better predicts HAND status. This suggests that an accurate assessment of neural injury at different frontostriatal regions (plus other key regions such as hippocampus and thalamus) may have the potential to serve as a biomarker to assist with HAND diagnosis and characterization. To test this hypothesis, we will investigate frontostriatal injury in PWH using two behavioral paradigms that are known to involve distinct frontostriatal regions, along with two advanced functional MRI (fMRI) techniques, fMRI- adaptation (fMRI-A) and multivariate pattern analysis (MVPA). Compared to conventional fMRI techniques, fMRI-A and MVPA techniques can better estimate neural tuning/selectivity that can be directly related to behavioral performance. Briefly, we hypothesize that frontostriatal injury — a central component in HAND — is highly prevalent in PWH and can be assessed behaviorally via two behavioral paradigms (Aim 1), and neurally via fMRI-A & MVPA (Aim 2). The integration of behavioral and fMRI data will help to assess the degree of neural injury at different frontostriatal and associated regions, which in turn may serve as a biomarker for HAND status (Aim 3). The probable impact of common comorbidities (e.g., history of substance and alcohol abuse, etc.) will also be investigated. In summary, this proposal is theoretically driven and highly innovative, with a strong promise for future clinically relevant development. The feasibility of the proposed research is supported by a strong foundation in cognitive neuroscience and neuroHIV, strong preliminary data, and an established research team. The success of this proposed project may help to develop sensitive behavioral tests that can effectively detect mild neurocognitive impairment in PWH, and a biomarker that can assist in determining HAND status/severity.

Public health relevance
PROJECT NARRATIVE In the era of combination antiretroviral therapy (cART), the prevalence of HIV-associated neurocognitive disorders, or HAND, remains high in people with HIV (PWH). Neural injury to the frontostriatal circuits has been proposed as a key component in HAND, but the precise neural mechanisms remain to be elucidated. Built upon rich cognitive neuroscience literature and inspired by recent findings in neuroHIV research, we propose a functional MRI (fMRI) study to investigate functional disruptions to the frontostriatal circuits in PWH, using a novel combination of established behavioral test paradigms and advanced fMRI techniques.